Mechanism of the short- and long-term effects of COVID-19-induced Alarmins on hematopoietic stem and progenitor cells.

ABSTRACT
The long-term goal of this proposal is to understand the long-term sequalae of acute COVID-19 infection on
hematopoietic and immune damages, and to identify the key pathways and mechanism by which COVID-19-
associated cytokine dysregulation alters HSC function and differentiation. SARS-CoV-2 infection causes local
and systemic damages due to dysregulated immune response and cytokine production. Its long-term negative
effects on body tissue and organ remain largely unknown. Our published work showed that SARS-CoV-2
infection dramatically increased neutrophil production and neutrophil-associated S100A8/A9 (Alarmin) release.
Persistent high level of S100A8/A9 is a negative prognostic biomarker for the disease severity and mortality.
Although the function of S100A8/A9 on mature blood cells have been studied, its functional effect on
hematopoietic stem cells (HSCs) are unknown. Our preliminary data show that S100A8/A9 causes loss of
quiescence and differentiation of HSC toward myeloid progenitors at the expense of HSCs. Toll-like receptor 4
(TLR4), the endogenous receptor of S100A8/A9, is highly expressed in HSCs, and S100A8/A9 activates its
canonical downstream MAPK (mitogen-activated protein kinase) pathway. Very interestingly, S100A8/A9 causes
downregulation of epigenetic regulator Setd2, leading to the c-Myc upregulation in HSCs. c-Myc is a key
downstream target of both MAPK and Setd2 pathways. MAPK, Setd2 and c-Myc are important regulators of HSC
proliferation and myeloid differentiation. We hypothesize that SARS-CoV-2-induced S100A8/A9 activates TLR4
signaling which converts to c-Myc in HSCs, resulting in loss of quiescence and self-renewal, myeloid
differentiation skewing, and long-term impairment of hematopoiesis. Since HSC is responsible for the life-long
production of blood cells, including all types of immune cells, any functional damages of HSCs would later on
have profoundly negative effects on the immune response. Therefore, understanding the cellular and molecular
mechanism by which S100A8/A9 regulates HSCs and hematopoiesis would contribute a new evidence base to
accelerate advances in diagnostics, therapeutics, clinical management of COVID-19 patients in acute infection
and recovery phases.
1

Public health relevance
PROJECT NARRATIVE We hypothesize that SARS-CoV-2-induced S100A8/A9 activates TLR4 signaling which alters hematopoietic stem cell (HSC) function and myeloid differentiation. Dissecting the detail mechanisms and pathways responsible for adverse and long-term outcomes of SARS-CoV-2 infection will help the diagnostics, therapeutics, and clinical management of COVID-19 patients in acute infection and recovery phases.